IMAGING &FCS OF SECRETORY PATHWAY IN GFP TRANSFECTED MAMMALIAN CELLS

Measurement methods for multiphoton photolysis cross sections of caging groups have been previously developed and applied to three commercially available cages 4,5-dimethyloxy-2-nitrobenzyl ester (DMNB) and ((-2-carboxy)-2-nitrobenzyl (CNB). We used CNB caged (-aminobutyric acid (CNB-GABA) for measurements of the properties of the CNB caging group, NPE-ATP as an NPE-caged compound, and DMNB caged fluorescein as a representative compound for the DMNB group. Recent results for the NPE cage using frequency doubled TiS excitation (450 nm, 200 fs pulses) reveal relatively larger (>3 GM) uncaging cross-sections which may prove to be a useful alternative to the short wavelength UV normally required for single photon photolysis of this cage (<350 nm).